Reversibility of brain glucose kinetics in type 2 diabetic subjects

Project summary/abstract
The prevalence of type 2 diabetes mellitus continues to rise worldwide and despite different treatment
options, many patients fail to achieve glycemic target, which leads to increased morbidity and mortality.
Chronic exposure to hyperglycemia has been shown in both animal and human studies to decrease glucose
transport into the brain, presumably through down-regulation of GLUT1 at the blood brain barrier, which has
been postulated to be a protective adaptation of the central nervous system against the harmful consequences
of hyperglycemia. However, GLUT1 down regulation may lead to reduced brain glucose metabolism leading to
neuronal damage, neurodegeneration and cognitive decline. Whether these changes in cerebral glucose
transport seen in patients with poorly controlled diabetes can be reversed is unknown. The main goal of this
study is to determine whether improvement of glucose control in poorly controlled T2DM patient will restore
brain glucose transport kinetics and rigorously assess which factors (i.e. duration DM and glycemic control)
contribute to the observed improvements by using classic metabolic studies as well as state-of-the-art brain
nuclear magnetic resonance spectroscopy (MRS) techniques. The findings obtained from this study will help
elucidate if intensive diabetes therapy may be associated with reduced brain dysfunction from hyperglycemia.

Public health relevance
Project Narrative: Chronic hyperglycemia has been associated with a decrease in brain glucose transport through down-regulation of GLUT1 at the blood brain barrier, findings that could be explained as a protective adaptation of the central nervous system against the harmful consequences of hyperglycemia. However, GLUT1 down regulation may lead to reduced brain glucose metabolism leading to neuronal damage, neurodegeneration and cognitive decline. This application will determine whether improvement of glycemic control in poorly controlled type 2 diabetic subjects would restore glucose brain transport kinetics by using classic metabolic studies methodology as well as state-of-the-art brain nuclear magnetic resonance spectroscopy (MRS) techniques.